The role of ATP citrate lyase in cardiac macrophage-mediated inflammation aftermyocardial infarction

Myocardial infarction (MI) is the number one killer in the Western world. Especially, war veterans are highly prone
to post-MI morbidity and mortality. Recent breakthrough technologies in the treatment of MI patients have
decreased in-hospital mortality. However, long-term morbidity and mortality due to complications, such as
reinfarction and heart failure, still persist. Several studies and the Canakinumab Anti-inflammatory Thrombosis
Outcome Study (CANTOS) have shown that inflammation plays a crucial role in these complications. Yet, the
exact mechanisms of exaggerated inflammation after MI are not clearly understood. Different pathways of
cellular metabolism, such as fatty acid oxidation and oxidative phosphorylation, can modulate inflammatory cell
function. In the proposed grant application, we will decipher the role of the fatty acid synthesis pathway in innate
inflammation. ATP citrate lyase (ACLY), an enzyme in this pathway, is well known for its role in histone
acetylation and transcription factor activation. However, if increased availability of this enzyme in macrophages
after MI augments cardiac inflammation and fibrosis by modifying the epigenome is not known. We will
investigate the role of ACLY in altering the epigenome of cardiac macrophages, leading to exaggerated
inflammation, excessive myocardial fibrosis, and deteriorated cardiac function after MI.

Public health relevance
War veterans have higher morbidity and mortality than the civilian population due to heart failure following myocardial infarction (MI). Recent preclinical and clinical studies have shown that inflammation is crucial to post- MI cardiac healing. However, the mechanisms of unleashed inflammation after MI are still not fully understood. De novo fatty acid synthesis is required for cell growth and proliferation. However, the role of this pathway in innate inflammation in disease conditions is not known. This proposed study will investigate how ACLY, an enzyme involved in this metabolic pathway, alters the epigenome in macrophages, leading to exaggerated inflammation, excessive fibrosis, and cardiac remodeling after MI.